HRS Yrs 29-34: Y32 SSA CoFunding

Project Summary/Abstract This represents one year of co-funding of the Health and Retirement Study by the Social Security Administration via Jointly Financed Cooperative Arrangement (JFCA) agreement with the National Institute on Aging. The purposes of this JFCA are to provide support for: • Core activities of the NIA-sponsored Health and Retirement Study (HRS), including oversight by the Data Monitoring Committee; • A longitudinal panel data set on consumption and time use of the U.S. population over age 50 in the HRS, known as the Consumption and Activities Mail Survey (CAMS); • The further development and dissemination of the RAND-HRS longitudinal data file; • The maintenance of longitudinal imputations/recodes of wealth measures that is part of the RAND-HRS data file; • Consent for linkage through support for in-person interviewing or other measures as may be necessary to seek consent while protecting public health; • The maintenance of an integrated Social Security earnings and benefits file; • The maintenance of weights to correct for potential bias in selected sub-samples of HRS respondents from missing linked administrative data; and, • The interviewing cost of the increased sample of minority households in their pre- retirement ages.

Public health relevance
Project Narrative This project is for one year of co-funding of the Health and Retirement Study by the Social Security Administration via Jointly Financed Cooperative Arrangement (JFCA) agreement with the National Institute on Aging. Support includes core data collection, Consumption and Activities Mail Survey (CAMS), data processing and dissemination, and consent for linkage.